Systemic, maternal and transgenerational effects of nutrient stress

PROJECT SUMMARY
Developmental responses to nutrient stress reflect systems-level regulation -- the entire animal and its progeny
can be affected. But how developmental physiology is coordinated across the animal and over generations is
not well understood. The long-term goal of this project is to understand the molecular basis of persistent effects
of nutrient stress in the roundworm C. elegans. The worm is an ideal model since it has evolved to thrive in
feast and famine and its short generation time facilitates multigenerational studies. Preliminary results show
that larval starvation causes germline tumors to develop during early adulthood (intragenerational effect), but
that reduction of insulin/IGF signaling suppresses tumors by promoting ferroptosis. They also show that mater-
nal dietary restriction protects progeny from starvation-induced tumors by reducing insulin/IGF signaling (inter-
generational effect). Our studies also demonstrate epigenetic inheritance of increased starvation resistance
and lifespan as well as altered gene expression following dauer arrest (transgenerational effect), and they sug-
gest that small RNAs in the germ line mediate these effects. These preliminary results lay the foundation for
mechanistic analysis of persistent effects of nutrient stress during development and across generations. The
premise of this proposal is that early-life starvation compromises developmental integrity, but parental or an-
cestral nutrient stress buffers progeny from starvation. The central hypothesis is that early-life starvation leads
to development of adult germline tumors, but maternal provisioning and epigenetic inheritance protect progeny
from such pathological effects of starvation. The objectives are to identify signaling and gene regulatory mech-
anisms that mediate adaptation to nutrient stress across generations. The central hypothesis is supported by
strong preliminary data as well as the literature. It will be tested with the following three aims: 1) Identify mech-
anisms by which reduction of insulin/IGF signaling suppresses starvation-induced germline tumors, 2) Identify
mechanisms by which maternal dietary restriction buffers progeny from pathological effects of early-life starva-
tion, and 3) Identify regulatory mechanisms that mediate epigenetic inheritance of starvation resistance. Genet-
ic, genomic, pharmacological and biochemical approaches will be used to complete these aims. This work is
innovative for developing models that facilitate mechanistic analysis of intra-, inter- and transgenerational ef-
fects of nutrient stress and for investigating ferroptosis as a tumor suppressor mechanism regulated by a FoxO
transcription factor and insulin/IGF signaling. The contributions of the proposed work will be identification of
regulatory mechanisms that mediate adaptation to nutrient stress across generations. These include mecha-
nisms by which FoxO transcription factors suppress tumors as well as mechanisms for inheritance of starvation
resistance. These contributions will be significant because they will fill critical gaps in understanding of how
nutrient stress affects development, maternal provisioning, and epigenetic inheritance. The deeply conserved
function of insulin/IGF signaling and FoxO factors suggests that mechanisms discovered will be conserved.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health given the paramount importance of nutrition on health and disease. Dysregulation of nutrient sensing pathways causes cancer and diabetes, and there is mounting evidence that diet affects disease risk across generations. This work will increase fundamental understanding of how animals adapt to nutrient stress, suggesting preventive strategies and therapeutic interventions to reduce public health burden.